Nou La We are Here Biomedical Prevention for People of Haitian Descent

PROJECT SUMMARY- Nou La (We’re Here): Biomedical Prevention for People of Haitian Descent
According to the Ending the HIV Epidemic Plan, Miami, Florida is considered a US HIV epicenter.1 In Miami,
Florida people of Haitian descent have been disproportionately affected by HIV.2 Haitian-born people had an
incidence of 5.5% of HIV and 9% of AIDS diagnoses.2 This planning project will develop an implementation
strategy “L’Union Fait La Force or (Unity Makes Strength): Increasing PrEP Reach” in which we will
partner with local organizations already trusted and utilized by the Haitian community to collaborate and create
new opportunities for PrEP access. The aims of this project are:
Aim 1: To characterize and prioritize knowledge and organizational determinants of PrEP implementation
at community-based organizations and clinics serving people of Haitian descent in Miami. Rationale: To
develop a relevant implementation approach that overcomes the current gap in PrEP uptake among people of
Haitian descent we will focus on the context of PrEP knowledge and delivery at sites that could provide the
medication but are not currently doing so and prioritize steps to achieve PrEP delivery. Approach: We will partner
with the Community Health and Empowerment Network (CHE), and Selest Health Center. We will conduct two
focus group discussions at each site with key stakeholders (providers, leaders, managers, and staff) and 30
interviews with clients (15 at each site) which will use semi-structured interview guides (developed with the
Haitian American Professionals Coalition) and will be analyzed using rapid qualitative analysis. Outcome: From
this aim, we will have a better understanding of PrEP educational needs and key elements for delivery from
those offering services to members of the Haitian community.
Aim 2: Using a community engaged approach design an implementation strategy to increase PrEP
uptake. Rationale: Understanding barriers, facilitators, PrEP knowledge and the delivery needs for
implementation is essential to develop culturally relevant interventions at community sites. Approach: Using
findings from the Bon Sante study and aim 1, we will iteratively work through discussions with study site partners
to develop a practical strategy that addresses leading individual (client) and service organization barriers to PrEP
uptake and delivery. Outcome: Through this process we will design an acceptable and testable implementation
strategy.
Aim 3: Test the acceptability and feasibility of a PrEP implementation strategy for people of Haitian
descent. Rationale: In order for interventions to be effective, it is important that they are acceptable.
Approach: We will conduct a survey and exit interviews with 5 participants from each site (n =10) who receive
PrEP and 4 key stakeholders from each site (n= 8). We will also record the number of people given information
regarding offered PrEP and the number of people who initiate PrEP. Outcome: Through this process, we will
have a measure of the acceptability and feasibility of the approaches to increase uptake of PrEP at the partner
sites.

Public health relevance
PROJECT NARRATIVE This proposal “Nou La” (We’re Here): Biomedical Prevention for People of Haitian Descent” will be used to develop an implementation strategy called “L’Union Fait La Force (Unity Makes Strength): Increasing PrEP Reach” which will increase the use of pre-exposure prophylaxis among people of Haitian descent in Miami, FL.